Neurological effects of aerosolized red tide neurotoxins

The observed increased occurrences of harmful algal blooms (HABs) are largely a consequence of ocean
warming due to climate change, eutrophication, and nutrient pollution, which raise concerns that HABs are
negatively impacting aquatic ecosystems, coastal resources and the health of coastal communities. Among
these HABs, Karenia (K.) brevis affects many Gulf Coast communities, particularly southwest Florida. Over the
last decade, K. brevis blooms have caused massive destruction to marine life and morbidity and mortality of
marine mammals. These harmful effects of K. brevis are attributed to the release of potent neurotoxins,
brevetoxins (PbTx). Currently, the impact of aerosolized PbTx exposure on the human central nervous system
(CNS) is not yet known. Human consumption of PbTx causes Neurotoxic Shellfish Poisoning (NSP), including
a wide range of neurological symptoms. We recently showed that SW Florida residents exposed to aerosolized
PbTx are experiencing NSP-like (NSPL) symptoms, and those with past medical histories (PMHx) of migraine
and chronic fatigue syndrome (CFS) were particularly vulnerable to the neurological effects of aerosolized
PbTx. Carriers of the apolipoprotein E (APOE) e4 allele who are genetically at a higher risk of cognitive
impairment more frequently experience memory problems and fatigue during red tide blooms. We have
detected PbTx in blood, and antibodies against PbTx correspond with the reporting of NSPL symptoms
following exposure to aerosolized PbTx. However, a dose-response relationship between aerosolized PbTx
exposure and the emergence of NSPL and neurological symptoms is currently unknown. Therefore, we will
determine a dose-response relationship between aerosolized PbTx exposure and NSPL and neurological
symptoms. We will determine whether individuals with preexisting neurological conditions or e4 carriers more
frequently experience NSPL compared to general residents and non-carriers. We will also determine whether
PbTx in biospecimens and blood PbTx antibodies can serve as biomarkers of NSPL and neurological
symptoms. Currently, there is no information available on PbTx pharmacokinetics (PK) in humans. Therefore,
we will determine the PK parameters using PbTx in biospecimens and determine their relationship to NSPL
and neurological symptoms. Using physiology-based PK modeling, we will estimate the amounts of PbTx that
can reach the human brain, which will be critical for understanding the adverse brain health effects from
aerosolized PbTx exposure. This work will inform future decision-making for developing strategies to minimize
the risks of neurological symptoms in humans following aerosolized PbTx exposure. Given the ongoing threat
of climate change on the formation of powerful hurricanes in the Pacific and Atlantic Oceans and the Gulf of
Mexico and subsequent occurrences of intense HABs in coastal waters, this poposed work will provide a
roadmap for future investigations into studying the adverse human health impact from exposure to HAB toxins.

Public health relevance
Warmer water in the Gulf of Mexico due to climate change, along with nutrient pollution of coastal waterways, have contributed to frequent and repeated Florida red tide (K. brevis) blooms, which impact large segments of gulf coast communities; however, the adverse effects of the neurotoxin, brevetoxin, produced by the algae, on the brain health remain unknown. This proposal will develop clinical tools and blood tests to detect aerosolized brevetoxin exposure- related adverse brain health effects on coastal residents, particularly those with preexisting neurological conditions or genetic predisposition to the harmful effects of environmental toxins. Ultimately, this work will help public health decision-making and developing strategies aimed at protecting the brain health of residents living in coastal communities who frequently endure exposure to harmful algal bloom toxins.